Pre-exposure Immunologic Health and Linkages to SARS-COV2 Serologic Responses, Endothelial Cell Resilience, and Cardiovascular Complications: Defining the mechanistic basis of high risk endotypes.

We propose a two-year collaborative project to synchronize data harmonization efforts and analyses of individual-level data in immunocompromised populations to assess effectiveness of vaccine boosters and immune responses using data from 11 Serological Sciences Network (SeroNet) institutions. Our goal is to inform public health guidelines on COVID-19 vaccine and boosters to reduce SARS-CoV-2 infection and severe illness in these vulnerable populations. To do so requires large datasets of well-defined populations with clinical information and a robust collaborative infrastructure able to evolve as new research questions arise during the pandemic. Therefore, we propose to mimic the NA-ACCORD strategy of pooling cohorts at multiple sites in North America (https://naaccord.org). The foundational work of the NA-ACCORD enabled them to rapidly pivot to establish the CIVET-II cohort collaboration during the pandemic. To be time- and cost-efficient, we propose a single pooling project that merges data from both (i) electronic medical records as well as (ii) prospective cohorts from SeroNet sites across the U.S. The cooperation of many SeroNet sites is crucial and will allow results to be more generalizable to the wider U.S. population, including investigation of sources of heterogeneity (e.g., age, sex, race/ethnicity and geography). Data harmonization efforts will be streamlined, and analyses will be divided by research area across all sites to allow multiple publications to occur simultaneously.

Public health relevance
Project Narrative COVID-19, the disease resulting from SARS-CoV2 infection, has caused immeasurable death and economic hardship across the globe within months. Certain individuals, including those with impaired immune function and/or those with heart disease appear to be a higher risk from COVID19. Whether survivors develop protection from a second exposure add to the urgency to understand the details of how COVID causes death. Here, we will characterize baseline differences in immunologic activation and risk factors for heart disease and how these relate to immune system function after infection. We will also compare those who do and don’t develop heart failure in response to COVID19, identifying ways the virus may directly or indirectly attack distant organs such as the heart. By identifying the mechanisms which explain why some develop life-threatening disease whereas others are minimally affected, we hope to develop strategies to identify and prevent severe illness from developing in those with COVID.